Modeling autoimmune pathogenesis and beta cell destruction by T1D immune systems

Project Summary
The study of Type 1 diabetes (T1D) pathogenesis has been limited by the insufficiency of animal models and
the heterogeneity of patient populations, who derive genetic risk from HLA and different assortments of about
60 non-HLA genetic variants. Given this complexity, there is a need for improved models of human T1D
pathogenesis involving diverse genetic backgrounds. We have developed humanized (HU) mouse models,
including one in which T1D patient and healthy control (HC) immune systems are generated de novo from
hematopoietic stem cells (HSCs) in Personalized Immune (PI) mice and models introducing transgenic (Tg)
autoreactive TCRs into their HSCs and T cells. We have developed methods of generating thymic epithelial cell
(TEC) progenitors and β cells from human pluripotent stem cells (hPSCs). We will use these tools to address
the hypothesis that HSC-intrinsic and thymus-intrinsic genetic variants in T1D individuals lead to
abnormal thymic selection of β cell antigen-autoreactive TCRs. We will: Aim 1: Determine the impact of
T1D-prone genotypes on selection of autoreactive T cells in the human thymus. We have demonstrated
negative selection of a Tg HLA-DQ8-restricted insulin B9-23 peptide-specific TCR in HLA-DQ8+ thymi of HU
mice. We will assess additional β cell-autoreactive class I- and class II-restricted TCRs, determine the impact
of both HSC and AIRE+ mTEC antigen expression and compare selection of T1D patient vs HC thymocytes
bearing β cell-reactive TCRs; Aim 2: Determine the impact of T1D-prone genotypes of TECs on thymic
selection of β cell-reactive T cells in humanized mice. We will utilize a novel model in which hPSC-TECs
create a “hybrid thymus” on a living scaffold of fetal pig thymic tissue that supports human T cell development in
HU mice. We will use this model with genetically engineered hPSCs to determine the impact of human TEC
expression of TID-associated genetic variants on selection of autoreactive TCRs; Aim 3: Assess autoimmune
interactions between hPSC-derived β cells and autoreactive T cells in humanized mice. We have
developed models for rejection of hPSC-derived β cells in HU mice and for autoimmune β cell destruction by
transducing autoreactive TCRs into their T cells. We have generated a hPSC cell line that lacks all HLA except
HLA-A2, evading rejection in HLA-A2+ immune systems. These will be used in vivo and in vitro, with and without
expression of an HLA Class II molecule, DQ8, to model autoimmune destruction by TCR Tg T1D patient and
HC-derived T cells, assessing the requirement for Class II HLA and CD4 help for CD8 cell-mediated autoimmune
β cell destruction. Our collaborative effort will generate novel and robust systems to model human T1D,
enhancing understanding of its pathogenesis and providing a platform for testing of immunotherapies.

Public health relevance
Project Narrative Type 1 diabetes is caused by autoimmune T cell attack on insulin-producing beta cells. The complexity of genetic risk factors for the disease, which are each small but very significant in sum, makes it impossible to model human disease with a single inbred mouse line. We have developed a method of generating T1D patient-specific immune systems de novo in immunodeficient mice that, combined with some unique genetic engineering methodologies in stem cells, we will use to model autoimmune disease development at the level of T cell development and propensity to attack beta cells.